The role of Wnt signaling in treating glucocorticoid-induced glaucoma

PROJECT SUMMARY/ABSTRACT
Glucocorticoid (GC)-induced ocular hypertension (OHT) and glaucoma (GIG) occur in ~40% of the general
population and ~90% primary open angle glaucoma (POAG) patients. Our published studies and preliminary
data show that canonical Wnt signaling activation inhibits glucocorticoid receptor signaling and GC-induced
OHT. We hypothesize that activation of canonical Wnt signaling inhibits GIG, and this inhibition requires nucle-
ar β-catenin, glucocorticoid receptor (GR), and epigenetic modification enzymes including HDAC1 and MeCP2.
Our goal is to elucidate the mechanism of GIG. Our objective is to inhibit GC-induced OHT without compromis-
ing GC’s anti-inflammatory effects. Our rationale is that Wnt activation is a potential approach to prevent and
treat OHT/GIG, and studying GIG will help us to better understand POAG. Here, we propose three specific
aims to test our central hypothesis. SA1. Explore how Wnt signaling modulates GC-induced OHT and anti-
inflammatory effects in mouse eyes. We will determine SA1.1) If canonical Wnt signaling activation inhibits
GC-induced OHT using canonical Wnt signaling reporter mice; SA1.2) If β-catenin is necessary for inhibiting
GC-induced OHT using conditional knockout mice; and SA1.3) If activated canonical Wnt signaling compro-
mises GC’s anti-inflammatory effects using mouse uveitis models. SA2. Determine the role of canonical Wnt
signaling in glucocorticoid responsiveness in human eyes. SA2.1) Determine if Dkk1 (a Wnt signaling in-
hibitor) is elevated while canonical Wnt signaling is inhibited. We will collect aqueous humor and trabecular
meshwork tissues from GIG eyes as well as from non-GIG eyes to study Dkk1, β-catenin and axin2 levels. We
expect to see higher Dkk1 levels but lower β-catenin and axin2 in GIG eyes. SA2.2) Determine if canonical
Wnt signaling affects GC responsiveness in human donor eyes. We will perfuse paired donor eyes with DEX to
identify responsiveness. For responder eyes, we will co-treat one eye with CHIR (a small molecule Wnt signal-
ing activator) and expect it will relieve OHT. For non-responder eyes, we will co-treat one eye with Dkk1 and
expect it will induce OHT. SA3. Determine the molecular mechanism of canonical Wnt signaling and β-
catenin in GC responsiveness and TM homeostasis. SA3.1) Determine Wnt signaling induced gene ex-
pression and associated chromatin accessibility in GC response. We will determine whether Wnt signaling has
differential regulation of GC-induced genes using RNA-seq and Assay for Transposase-Accessible Chromatin
with high-throughput Sequencing (ATAC-seq). SA3.2) Determine the role of β-catenin-GR/HDAC1/MeCP2 nu-
clear complex in regulating GR signaling. The components and binding pattern of this complex will be deter-
mined using Co-IP, Mass-Spec, FLIM-FRET, and ChIP-qPCR. In summary, we propose a novel approach to
remove GC side effects without compromising its therapeutic effects. The compound that we test may serve as
a lead compound in future drug development for GIG, and it would enable long-term, undisrupted use of GCs
for various eye diseases upon the success of this study.

Public health relevance
PROJECT NARRATIVE The project is relevant to public health because studying how Wnt signaling affects glucocorticoid-induced changes in the trabecular meshwork is ultimately expected to increase our understanding of the pathogenesis of glucocorticoid-induced glaucoma and provide therapeutic targets to the development of safer glucocorticoids. Therefore, the proposed research is relevant to the part of NEI’s mission that pertains to developing fundamental knowledge with respect to blinding eye diseases.